Computing Core

COMPUTING CORE
SUMMARY
The Computing Core supports the research computing needs of participating faculty members
in the Center for Visual Science. The Computing Core supports the services of three
applications programmers/engineers who provide CVS faculty with the expertise to develop
customized software platforms and novel instruments that enable new research directions.
Computing core staff bring years of expertise with 3D graphics programming, real-time control
of hardware, image acquisition and analysis, distributed network analysis, and many forms of
sophisticated data processing. During the coming project period, the Computing core will
contribute to a number of new research directions, including remotely monitored visual training
for stroke patients using virtual reality, behavioral evaluation of new approaches to vision
restoration based on optogenetic and stem cell therapies, and imaging approaches for real-time
measurement of eye movements, retinal blood flow, and fluorescent reporters of neural activity.